CHOICES for Sickle Cell Reproductive Health: RCT of a Preconception Intervention Model for a Single Gene Disorder

Project Summary/Abstract
Our long-term goal is to foster genetically-informed reproductive health knowledge and behaviors among
young adults with sickle cell disease (SCD) or sickle cell trait (SCT) with a web-based, tailored, multimedia
intervention (CHOICES). In follow-up to genetic counseling, CHOICES helps them engage in behaviors
concordant with their parenting plan. Developed with the sickle cell community, CHOICES is designed to help
young adults with SCD or SCT gain knowledge of genetic inheritance, specify their preconception reproductive
health intentions (their parenting plan), and engage in reproductive health behaviors concordant with their
parenting plan. We found high acceptability of both the e-Book (usual care control) and CHOICES
interventions. We also found sustained (24 mo), significant effects on knowledge but not on at behavior,
presumably because 49% of the participants were not at risk of having a child with SCD (e.g., partner had
normal hemoglobin, Hgb A). Of the participants at risk of having a child with SCD (at-risk) and who expressed
intention to get pregnant soon and have a child free of SCD, the CHOICES group’s (n=26), behaviors showed
a 27% relative at-risk time reduction compared to the e-Book group (n=16). However, the difference was not
statistically significant given the small, underpowered sample (n=42). Hence, we propose an adequately
powered RCT with the CHOICES intervention and an e-Book control to compare their effects on genetic
inheritance knowledge and at-risk reproductive health behaviors (immediate posttest and at 6, 12, 18, & 24
mo). Using proven strategies (referrals, social media, and communication technology) for recruiting and
retaining the sample, we will use web-based data collection (SCKnowIQ) and intervention delivery strategies
enhanced by nudges and tailored boosters. In a sample of 430 adult men and women, aged 18-35 yr with SCD
or SCT, at-risk, and planning within 2 years to have a child free of SCD, the specific aims are to: Aim 1.
Compare e-Book and CHOICES groups for effects on (a) knowledge (primary endpoint), and (b) at-risk
behavior (secondary endpoint) measured with the SCKnowIQ over time (baseline, post-test, 6,12, 18,24 mo).
We hypothesize that across all time points post baseline, there will be (a) higher knowledge scores and (b)
lower percentage of time with at-risk behaviors (at-risk time) in the CHOICES than in the e-Book groups.
Aim 2. Explore the relationship between demographic factors (e.g., sex, SC status), intervention acceptability,
and the Aim1 endpoints (knowledge, behavior). We will conduct subgroup analyses to provide insight into the
baseline knowledge and behavior as well as the intervention effects in different demographic or acceptability
groups. Given the scalability and low cost of CHOICES, if proved to be effective, it can reach the affected
population at low cost. As a genetic counseling follow-up model, CHOICES may translate into informed
parental decisions and preparedness for the consequences of their preconception decisions. Considering the
implications for SCD and other single-gene diseases globally, the potential impact is enormous.

Public health relevance
Project Narrative Our goal is to foster genetically-informed reproductive health behaviors concordant with informed parenting plans among young adults with sickle cell disease or sickle cell trait, who intend to have a child free of sickle cell disease, but are at risk for their children inheriting the disease. Our intervention is designed to help them understand the inheritance of sickle cell disease and the many ways they can consider to implement their informed parenting plan. If successful, CHOICES could become widely available as a preconception intervention that helps young adults to understand the genetic inheritance of sickle cell disease and ways acceptable to them for reducing the risk of their child inheriting the disease.